Seasonal Conjunctivitis Outbreak Reporting for Prevention and Improved Outcomes (SCORPIO)

PROJECT SUMMARY/ABSTRACT
Seasonal and epidemic conjunctivitis (pink eye) infections are highly contagious and impose significant
economic burden in the United States and worldwide. Long-term visual impairment can occur. In children,
conjunctivitis may herald more serious systemic complications leading to hospitalizations and even deaths.
Current challenges to effective mechanisms to curtail outbreaks are the lack of tracking and reporting, poor
access to sample collection for analysis, limited diagnostic testing capabilities, and an incomplete
understanding of the pathogens involved. The overall goal of this project is to combine international
collaboration efforts and advances in genomic technologies to identify pathogens, global trends, pathogen
evolution, and the immune responses involved in the epidemiology of conjunctivitis. We propose to enhance
the understanding of the pathogenesis of conjunctivitis with the following aims. The first aim will determine how
adenovirus genome types vary within a region and across regions. The second aim will identify emerging
causes of seasonal and epidemic conjunctivitis. Finally, we will identify the local immune response signatures
of children and adults with infectious conjunctivitis. We expect that conjunctival gene expression profiles will
accurately predict disease associated complications. This project has the potential to improve public health
surveillance, guide targeted interventions, improve vaccine development, and elevate existing diagnostic
paradigms for conjunctivitis, to reduce both the financial and ocular health burden worldwide.

Public health relevance
PROJECT NARRATIVE (RELEVENCE) Conjunctivitis results in significant economic burden worldwide and can result in long-term vision impairment and severe systemic complications in children. This project takes advantage of international collaborations and recent advances in genomic technologies to enhance our understanding of conjunctivitis epidemics globally by identifying the pathogens involved, characterizing the evolution of pathogen genomes across time and space, and defining the immune responses to these infections. The results of this study will improve prevention methods and help to curtail spread, thus reducing the burden on cost and human ocular health.